Antagonism of RANKL signaling by estrogen in osteoclasts

PROJECT SUMMARY/ABSTRACT
Loss of estrogens at menopause is a major cause of osteoporosis due to an increase in number and activity of
the cells that resorb bone called osteoclasts. Estrogens inhibit bone resorption in part via direct effects on
osteoclasts. However, the cellular and molecular mechanisms responsible for the direct effects of estrogens on
osteoclasts remain unclear. The work proposed in this application seeks to identify the molecular mechanisms
by which estrogens directly control osteoclast number, function, or both. We found that estrogens prevent an
early stimulatory effect of RANKL – the indispensable cytokine for osteoclast differentiation – on mitochondria
respiration and ATP production in osteoclast progenitors. Evolutionarily Conserved Signaling Intermediate in
Toll Pathway (ECSIT) is a mitochondria complex I-associated protein that regulates immune responses in
macrophages in response to inflammatory signals. We found that ECSIT is essential for RANKL-induced
stimulation of mitochondria activity and ATP production and a target for the anti-osteoclastogenic effects of
estrogens. Estrogens also decrease NAD+ levels and NAD+/NADH ratio and promote the mitochondria
pathway of apoptosis. The above observations form the foundation of the hypothesis that estrogens reduce
osteoclast number and bone resorption by inhibiting RANKL stimulation of mitochondria, decreasing NAD+,
and promoting mitochondria-mediated apoptosis. The work proposed will elucidate the independent
contribution of ECSIT, NAD, and apoptosis to osteoclastogenesis and the effects of estrogens. We will also
identify possible interactions among these pathways. To test the hypothesis, we will determine whether ECSIT
stimulation of mitochondria activity is required for the bone loss caused by estrogen deficiency. This will be
accomplished using mice lacking ECSIT in osteoclast lineage cells. In addition, we will examine the
contribution of NAD to the estrogen deficiency-dependent increase in bone resorption using mice with loss-of-
function of Nampt – an essential enzyme of the NAD salvage pathway – in osteoclast lineage cells. We will
also overexpress mitochondria-targeted water-forming NADH oxidase from Lactobacillus brevis (LbNOX) in
osteoclast cultures to examine the contribution of altered NAD+/NADH redox ratio to the effects of estrogen.
Finally, we will investigate whether estrogens decrease osteoclast number by promoting mitochondria-
mediated cell death using mice with simultaneous deletion of Bak and Bax – proteins required for mitochondria
mediated apoptosis – in osteoclast lineage cells. To distinguish effects of estrogen in progenitors versus
mature osteoclasts, we will examine changes in number and gene expression profiles of osteoclast lineage
cells in vivo and in vitro using single cell RNA sequencing. Successful completion of this work should establish
novel mechanisms that contribute to osteoclast development and its regulation by estrogens.

Public health relevance
PROJECT NARRATIVE A decrease in bone mass is one of the most common features of menopause (loss of estrogens), but the mechanisms responsible for this effect remain unknown. The aim of the work proposed in this application is to identify the means by which estrogens decrease the number and activity of the bone-resorbing cells. Knowledge gained with these studies may prove useful for the development of therapies that can treat osteoporosis.